Admin Core

Project Summary- Administrative Core
The Administrative Core of the “Immunobiology and Immune Therapy for Merkel cell carcinoma”
P01 will provide overall direction, coordination of the Scientific Advisory Board meetings, as well
as administrative, regulatory, and fiscal oversight to the three Projects and the three Shared
Resource Cores (Specimen & Data, Immunopathology, and Bioinformatics & Biostatistics). The
Administrative Core will provide an effective organizational structure to expedite research and
promote communication between Program Project components and investigators and the
scientific and patient communities. The Administrative Core is responsible for strategic planning,
as well as effective organizational structure among the performance sites (Fred Hutchinson
Cancer Center, University of Washington, University of Virginia, and University of Michigan).
The Administrative Core is responsible for research effort coordination and allocation of NIH
funds. This Core will also manage fiscal components of the Program Project including
reallocation of funds to optimize overall function, and resolution of potential conflicts in a fair and
equitable manner to maximize progress of the Program. The Administrative Core is responsible
for communication including dissemination of information relevant to the Program via email,
Zoom teleconferences, as well as in-person meetings. In addition, The Core will provide
strategic outreach to the patient, physician, and scientific communities through maintenance
and updates of the merkelcell[.]org website (which reaches >82,000 unique users each year),
coordination with our MCC patient advocates, and organization of the MCC Multicenter Interest
Group annual meeting. The mission of this Core is to ensure regulatory and administrative
compliance including reporting to the Scientific Advisory Boards and NIH as well as to support
and sustain optimal efficiency of the Projects and Cores of the Program.

Public health relevance
Narrative: Administrative Core The Administrative Core will provide overall direction, coordination of the Scientific Advisory Board meetings, as well as administrative, regulatory and fiscal oversight to the three Projects and the three Shared Resource Cores (Biostatistics & Bioinformatics, Immunophenotyping, and Specimen & Data). The Administrative Core will provide an effective organizational structure to expedite research and promote internal communication between Program Project components and investigators, and externally to the scientific and patient communities.